Orally available NOD2 agonist, HPX-612, for the treatment of visceral leishmaniasis

Project Summary
We are developing the first orally available immunotherapy product, HPX-612, for the treatment of visceral
leishmaniasis, a parasitic disease caused by Leishmania and transmitted by sandflies. Visceral leishmaniasis
remains endemic in 65 countries worldwide, with over 4 million people impacted globally. Current treatment
options require lengthy and painful injections and have significant limitations including low therapeutic index,
severe side effects, acute cytotoxicity, high associated hospital costs and emergence of their resistance strains.
Additionally, these treatments are often inaccessible to those living in the remote areas where Leishmania is
prevalent. Leishmania infection is heavily dependent on host monocytes and macrophages as once the parasite
enters the human body, it is engulfed by monocytes and macrophages where it inhibits macrophage activation
and replicates. Recent studies have identified the nucleotide-binding oligomerization domain-containing protein
2 (NOD2) as a critical regulator in the intracellular killing of Leishmania parasites. Further, NOD2 agonism in
infected monocytes and macrophages provide a novel host-targeted therapeutic strategy that increases
immunosurveillance via activation of the innate immune system that resolves leishmaniasis.
HPX-612 is a novel lipid nanoparticle and potent innate immune stimulator that is comprised of the active
pharmaceutical ingredient muramyl tripeptide phosphatidylethanolamine (MTP-PE), a NOD2 agonist with
demonstrated clinical safety. MTP-PE is the active pharmaceutical ingredient in the EMA-approved intravenously
delivered MepactÒ for non-metastatic osteosarcoma. HPX-612 has a demonstrated capacity to cross the gut-
blood barrier creating a sustained NOD2 stimulation and potent pro-inflammatory conversion of monocytes and
macrophages after oral dosing. When approved, HPX-612 will be delivered external to hospital settings and over
longer time periods to efficiently combat visceral leishmaniasis in regions that need it most. Herein this
application we will evaluate the preclinical pharmacokinetic profile of HPX-612, optimal posology, and
confirmation of efficacy in a murine model of visceral leishmaniasis. These results will support the launch of
HPX-612 into full-scale preclinical development for the treatment of leishmaniasis and a future Phase II
application.

Public health relevance
Project Narrative The aim of this project is to advance HPX-612, the first orally available immunotherapy that activates the innate immune system, for the treatment of visceral leishmaniasis. Visceral leishmaniasis, caused by the parasite Leishmania, is prevalent in low- and middle-income countries, and current treatment options such as liposomal amphotericin, pentavalent antimonials, and miltefosine are associated with significant toxicity and long treatment duration, often requiring hospitalization. As a result, up to 400,000 individuals annually experience significant morbidity and mortality. Herein this proposal, HPX-612 will be evaluated for efficacy in leishmaniasis, including its pharmacokinetics and optimal dosing, before launching into rigorous pre-clinical development program.